Mechanism of transcription-associated genome instability

Project Summary for NOT-GM-22-009 (PA-20-272) supplemental application included in Research
Strategy Section.

Public health relevance
Project Narrative not required for NOT-GM-22-009 (PA-20-272) supplemental application.